Chemokine receptor signaling and the dynamics of neutrophil phenotypes during inflammatory lung injury

PROJECT SUMMARY / ABSTRACT
Neutrophils are essential for host defense during bacterial infections, but their excessive activation can also promote
tissue injury. Recent studies suggest that there are distinct subsets or states of neutrophils that allow them to engage
in both exacerbation of inflammatory injury as well as repair and regeneration during the post-injury phase.
Chemokine receptors such as CXCR2 and CXCR4 are expressed differentially on selected neutrophil
subpopulations and are thought to regulate the trafficking of neutrophils between the bone marrow and the tissues
during acute infections. However, the precise dynamics of how distinct neutrophil subpopulations are trafficked and
how they contribute to discrete phases during lung injury and repair remain unclear. Identifying the distinct roles of
CXCR2 and CXCR4 receptor signaling would allow for precision therapeutic targeting of neutrophil subpopulations
in order to allow for their necessary host defense function during lung injury, minimize tissue injury caused by
maladaptive neutrophil subpopulations and also enable resolution and repair of lung tissue in the post-acute phase.
We have designed novel peptides that allosterically target CXCR2 and CXCR4, and our Supporting Data also
suggest novel molecular mechanisms by which these chemokine receptors signal. We have furthermore studied
phenotypes of activated neutrophils and assessed the dynamics of distinct neutrophil populations in the lung
following inflammatory lung injury. Based on our provocative Supporting Data, we have formulated the overarching
hypothesis that neutrophil subpopulations can be therapeutically targeted during key phases of inflammatory lung
injury to minimize lung injury without compromising host defense or lung repair. We propose the following specific
aims: In Aim 1, we will define the dynamics of neutrophil subpopulations in the bone marrow, blood and lung during
the progression of injury using lung injury models and targeted genetic interventions to study the roles of neutrophils
during distinct phases of lung injury and repair. In Aim 2, we will define the receptor clustering and signaling
mechanisms for the chemokine receptors CXCR2 and CXCR4 in neutrophils. In Aim 3, we will assess the
therapeutic efficacy of targeting neutrophil subpopulations during discrete phases of inflammatory lung injury.

Public health relevance
NARRATIVE Our immune cells are required to fight bacteria and viruses but it is also important for immune cells to help repair infected organs such as our lungs once the infection is over. It is therefore necessary to understand the functions of these different immune cells so that overactive immune cells that might damage the lung can be treated. The research in this proposal will identify the different types of immune cells during lung infections and find ways how to help resolve lung inflammation as well as increase the repair of the lung after the infection is resolved.